Regulation of Skeletal Growth and Regeneration

Growth, structure and regeneration of the skeleton remain areas of intense research activity, due to
their importance and relevance to body function and quality of life. The major engines of skeletal growth are
the growth plates that are composed of a top reserve zone rich in stem cells followed by proliferating, pre-
hypertrophic and hypertrophic zones of chondrocyte maturation and ossification, with cells organized in
columns. Growth plate-like structures also form during skeletal repair and regeneration as observed in bone
fracture healing. Growth plate activity is regulated by multiple mechanisms including signaling proteins such
as hedgehog and fibroblast growth factor family members; transcription factors including Runx2 and Mef2c;
and local and systemic hormones. The growth plates normally remain active until the end of puberty and then
undergo involution and close, establishing a fully grown skeleton. However, trauma, genetic disorders or drug
treatment of certain pediatric pathologies can have side effects on growth plates, derange proliferation and
maturation rates and cause slowdown and involution, often with severe skeletal consequences. For example,
about 10% of adolescents with a growth plate injury in long bones develop asymmetric bone growth and
require challenging surgical intervention. An example of genetic conditions is children affected by Crouzon in
which the cranial base growth plates malfunction and cause skull defects. Drug-induced growth plate
malfunction is observed in pediatric patients treated with pharmaceuticals that can have unwanted side effects
on their growth plates, causing growth retardation. In sum, the growth plates are vulnerable to malfunction in
several acquired and congenital pathologies, representing an unmet clinical need in search of solutions. In this
new project, we have used a standard model of growth plate defect in juvenile mice that mimics a pathology
seen in pediatric patients. Preliminary data suggest that growth plate dysfunction was caused by concurrent
changes in mechanisms normally fine-tuning growth plate activity and functioning. Additional data suggest
that systemic treatment with a drug targeting one such mechanism was able to maintain growth plate function
and restore skeletal lengthening. Our hypothesis is that growth plate dysfunction is amenable to drug-based
rescue. Aim 1 will assess growth plate dysfunction and genes involved in it. Aim 2 will delineate the cellular
mechanisms underlying dysfunction and rescue. Aim 3 will test the overall effectiveness and safety of the
pharmacological treatment and its range of action. We will use transgenic mouse lines, in situ hybridization,
protein analysis and treatment, biochemical approaches, and cultures of primary cells to delineate the
mechanisms of growth plate defects and means to counter them. We will utilize strict and unequivocal rules to
ensure scientific rigor and robust and unbiased design, methodology, analysis, interpretation, and reporting of
data. The project is geared to further test mechanisms of growth plate activity and will exploit the resulting
information to test new tools of therapeutic intervention on growth plate defects.

Public health relevance
Narrative Defects in growth plate activity can be triggered by genetic conditions, physical trauma or side effects of drug treatment, causing skeletal and body growth retardation, misalignment of skeletal elements, skeletal disproportion, limited physical mobility and/or other health problems. There are few if any effective treatments to ameliorate this pathology at present, and this project thus aims to further clarify the mechanisms of growth plate dysfunction and test specific therapeutic treatments to prevent or ameliorate it.